Administrative Core

Project Summary/Abstract
The Administrative Core is responsible for managing all project and core resources and ensuring compliance
with all governmental and specific NIH regulations and requirements, including timely communication and
consultation with project offices and other NCI staff. The core will convene all necessary meetings, including
monthly meetings of the internal oversteering committee and annual meeting of the external scientific advisory
committee. The specific aims are: Specific Aim 1. Maintain and further develop a database for
epidemiological, genetic and biomarker data. The Mt. Sinai group in Toronto has harmonized data from 80
studies comprising 125,000 lung cancer patients and more than 1 million cohort individuals. The availability of
this resource for Program Project leaders allows the proposed projects to be launched rapidly, efficiently and
effectively. Specific Aim 2. Provide Integrative Support for Program Project Activities. A primary function
of this core is to ensure the efficient functioning of Program Project relationships and communication.
Communication is supported by development of clear guidelines of communication and authority, procedures for
proposing new projects, regular teleconference calls, and maintenance of a website that collects and manages
results from all meetings. Specific Aim 3. Develop and evaluate the translation of findings in diverse
populations. A new component focusing on implementation science will be led by Washington University in St.
Louis. This component leverages their implementation science core to support projects that assess the impacts
of personalized evaluation and of messaging of smoking’s impact upon lung cancer risks and its mitigation, with
an emphasis on minority populations. The core component also uses the Qualitative Research Core available at
the Vanderbilt University Medical Center to advice in conducting focus groups targeting different communities,
including minority populations that are typically underserved, in evaluating genomic risk and in the LDCT
screening program.Specific Aim 4. Ensure compliance of the Program Project with all Regulatory
Requirements. The administrative core supports the development of protocols that support studies. It
coordinates relationships with dbGAP and other entities for whom data transfers are required. It will also manage
all communications with NCI programmatic, technical and administrative staff. The administrative core also
oversees financial management and ensures timely management of financial relationships among the Projects
and Cores. The administrative core plays a central role in supporting investigator interactions and ensuring
completion of aims. Administration for the P01 builds from successfully completed studies led by our teams of
investigators across a distributed network that is managed by clear communications and extensive
documentation.

Public health relevance
Project Narrative The administrative core ensures that data and processes needed to support all needs for the Integrative Analysis of Lung Cancer Risk and Etiology – Application and Translation program project are met. The administrative core also supports early stages of implementation science to translate findings from discovery science to communities at risk for lung cancer development.